Mechanisms of resistance to Androgen Receptor inhibition in prostate cancer

Prior studies investigating the interaction between PI3K pathway signaling and AR activity in cell lines and genetically engineered mouse models described a correlation between PTEN loss and resistance to AR-targeted therapy. We are using cell lines, patient derived xenografts, and organoid cultures from PDXs to investigate interactions between PTEN loss and resistance to AR-targeted therapy. We have identified a surprising resistance mechanism that is enhanced in models lacking PTEN, which is predicted to provide resistance to AR-targeted therapy. We are now working on identifying the mechanism whereby this resistance pathway is upregulated and ways to overcome it.